Peptide Nucleic Acid (PNA) Oligomers for Targeted Disruption of Biomolecular Condensates in ALS/FTD

PROJECT SUMMARY
The formation of biomolecular condensates (BMCs) is an important phenomenon in biology, creating transient
compartments that can accelerate biochemical reactions or sequester molecules during times of stress.
Aberrations in BMC formation are implicated in a growing number of diseases. Thus, molecular tools that enable
researchers to monitor and manipulate BMCs are in great demand. Ideally, these tools could be deployed without
engineering the biomolecules that drive BMC formation in order to avoid artifacts introduced by altering the
sequence of the RNA or protein components. Our proposal is focused on developing RNA-targeting probes that
can be used to (a) fluorescently label RNAs suspected of participating in BMCs and (b) disrupt specific RNAs
from entering BMCs. The molecular probes we will use for these experiments are based on peptide nucleic acid
(PNA), a synthetic version of DNA in which the natural sugar-phosphodiester backbone is replaced by an
extended peptide. Hybridization of the PNA to its RNA target will be used to introduce a fluorescent dye for
visualization in microscopy. Moreover, PNA hybridization should prevent that region of the RNA from either
binding to a protein or interacting with other RNAs, blocking its incorporation into a BMC. The advantage of this
approach is that the RNA target need not be modified in any way, i.e. we will target endogenous RNAs.
Additionally, the PNA can be introduced in a reversible manner, meaning it can be removed from the RNA at
any time, releasing the RNA to participate in BMC formation when the researcher deems it appropriate.
Our model system will be the C9orf72 gene bearing expanded repeats having the sequence G4C2/C4G2. The
resulting RNAs, both of which are present due to bidirectional transcription, have been implicated in numerous
toxic gain-of-function phenomena that are central to the pathology of amyotrophic lateral sclerosis (ALS) and
frontotemporal dementia (FTD). PNAs that can block the entry of these RNAs into BMCs can help assign roles
to specific molecular components of these complex, multicomponent condensates. Moreover, since numerous
neurodegenerative diseases feature expanded repeats of other sequences, the tools we develop in this project
can be readily adapted to other targets and diseases, greatly enhancing the potential impact of our proposed
research. Finally, while antisense approaches targeting the C9orf72 RNA have not yet led to viable therapies, it
is possible that the high affinity of PNA and a focus on targeting both of the expanded repeat transcripts will offer
better outcomes.

Public health relevance
PROJECT NARRATIVE Biomolecular condensates (BMCs) are compartments formed within cells that contribute to normal biological function but can be dysfunctional in certain diseases, including ALS and FTD. The goal of this project is to create a new class of molecular tools known as PNAs to manipulate and monitor formation of BMCs so that we can better understand the mechanisms by which they form and how their dysregulation can lead to diseases. Our PNAs will accomplish this by targeting specific RNA components of BMCs and either making them fluorescent for visual detection in a microscope or blocking their incorporation into BMCs to study the effect on the cell.